Endocrine and Metabolism Training Grant

This revised renewal application seeks support for continuation of a highly successful, multi-center and multi-
departmental training program at UT Southwestern Medical Center that provides M.D. and Ph.D. trainees with
a firm basis in state-of-the-art methodologies and to prepare them for future academic careers in metabolism
research. The program under the auspices of this T32 has been running for the past 39 years. Established
investigators from several Departments and a number of Centers join forces to provide our trainees with a
multi-facetted and diverse training program. Participating Centers include the Touchstone Center for Diabetes
Research, the Center for Hypothalamic Research, the Center for Human Nutrition, the Advanced Imaging
Research Center, the McDermott Center for Human Genetics, Center for the Genetics of Host Defense and the
Simmons Cancer Center. Areas of expertise include systemic and cellular metabolism, diabetes, lipid
biosynthesis, obesity, human genetics related to metabolic disorders and tumor metabolism. Our T32 mentors
direct highly competitive research programs of national and international stature. Our trainees can take
advantage of a very strong research infrastructure that allows them to address physiological, biochemical and
cell biological problems with emerging technologies and the latest instrumentation. The 41 trainers chosen
form a tightly interwoven, highly integrated group of investigators that cover all of the relevant areas in
metabolism research and a number of subspecialties in endocrine research. Metabolism research at UT
Southwestern has flourished over the past 5 years due to the programmatic expansion over the previous
period from 2007-2012. The school has made a major commitment towards complementing existing areas of
expertise by targeted recruitment of key personnel to fill existing gaps over the past decade. Here, we build
upon the historic strengths of our training program, while taking advantage of the programmatic expansion
experienced at UTSW. This T32 is an important cornerstone of metabolic research at UT Southwestern. We
have successfully implemented a number of changes proposed in our previous application to further improve
the quality of the training experience we provide. During the previous funding period (2011-2017), 12 trainees
completed the program or are currently in the program. 6 Trainees who have completed 1 or 2 years on the
Training Grant have successfully obtained F32, K08, K99 or American Cancer Society Post-Doctoral
Fellowship support. 2 additional K08 awards are pending. The remaining 3 have applied, but did not get
fundable scores. Of the 12 fellows supported, 2 hold senior scientist positions in industry, 6 hold faculty
positions in academia, 2 are still post-doctoral fellows with their own funding, and 1 is still actively supported by
the grant. The current epidemic of obesity and its pathophysiological sequelae are on the rise. It is paramount
to train the next generation of metabolism researchers and endocrinologists to cope with this enormous public
health problem and to develop innovative approaches to combat metabolic dysfunction.

Public health relevance
Endocrine disorders such as diabetes, obesity, dyslipidemias, thyroid disease, and polycystic ovarian syndrome are associated with enormous costs, both with respect to their morbidity and mortality and in their burden on the health care system. This proposal aims to provide resources that train young investigators at the MD or PhD level who will play a key role in extending our understanding of basic metabolic processes at the subcellular, cellular, organ and system level and in translating these new insights into both mechanistic and translational advances for disorders related to metabolic dysfunction.